Pediatric Oncology Program

The Program is designed to promote this translational research mission by fostering integration and identifying key gaps. The membership has grown strategically to cover the majority of major themes in the field of pediatric oncology, and we currently have focused research efforts in: 1) Genetics, Genomics and Epidemiology; 2) Biology and Signal Transduction; 3) Immunobiology and Transplantation, 4) Drug Development, Clinical Pharmacology and Clinical Research; and 5) Survivorship, Psychology and Outcomes.